Roles of vaccine perturbations on germinal center dynamics

PROJECT SUMMARY/ABSTRACT
Human immunodeficiency virus (HIV) lacks a vaccine despite being a global priority. HIV poses a unique
challenge to vaccine design, as many characterized broadly neutralizing antibodies (bnAbs) possess unusually
high frequencies of somatic hypermutations. To generate potential bnAbs, B cells must undergo iterative rounds
of affinity maturation and selection within germinal centers (GCs).
Our lab and collaborators have made significant contributions to the HIV vaccine field. These contributions
include sequential immunization strategies to efficiently prime bnAb-precursor B cells to enter GCs and to
increase the diversity and length of the GC. Despite our success with these regimens in preclinical models, our
understanding of sequential immunization strategies impacts to the GC microenvironment is lacking. We
hypothesize that the formulation of an immunization regimen i) can directly influence antibody-secreting and
memory B cell differentiation and ii) this is driven by the remodeling of the GC microenvironment. These
hypotheses will be tested using different mouse models with sequential immunization strategies designed to
track antigen-specific GC B cells and stromal cells. A combination of multiparameter flow cytometry, high
resolution microscopy, RNA-sequencing, ELISA, and ELISpot techniques will be used throughout the proposed
work.
These investigations including the studies of the stromal network underlying the GC microenvironment is a
largely underappreciated facet for the generation of adaptive immunity. This work has the potential to reveal
novel considerations for the formulation of HIV vaccines with the capacity for long-term retention of B cells within
GCs to generate bnAbs.

Public health relevance
PROJECT NARRATIVE Successful vaccines prime B cells to generate antibodies capable of neutralizing a pathogen. A successful HIV vaccine remains elusive. Characterizing the biology of immunization regimens will provide fundamental considerations for HIV vaccine design.